Research Methods in Pediatric Cardiovascular Disease

ABSTRACT
The goal of the Research Training Program in Pediatric Cardiovascular Disease is to attract and train highly
qualified MD, MD-PhD, and PhD scientists dedicated to advancing the understanding, diagnosis, treatment,
and prevention of pediatric and congenital heart disease. The program is based in the Department of
Cardiology at Boston Children’s Hospital (BCH), a leading national and international center for pediatric
cardiology and treatment of congenital heart disease. The 34 Faculty Mentors in this T32 include outstanding
and highly collaborative scientists - drawn from BCH, Harvard Medical School (HMS) and its affiliated
hospitals, and MIT - with expertise in basic, translational, and clinical research relevant to pediatric
cardiovascular disease. Together, they hold $34.9M in total support for the current year. Of those supported in
the past 15 years, 91% remain active in research, 76% continue in academia, and 18% are from under-
represented groups. A Research Training Executive Committee (RTEC), comprising the Program Directors
and four current mentors, will oversee the progress of fellow training, career development, and mentoring,
approve new mentors, and ensure that existing mentors meet the metrics of the training program. We are
requesting 8 trainee positions, on average supporting the training of 4 with MD or MD-PhD degrees and 4 with
PhD degrees each year. Entry into the T32 training program is highly competitive – from our highly talented
candidate pool, ~7% are selected for T32 support. We will expose trainees to the clinical, translational, or basic
research techniques that represent the current state of the art. A Core Curriculum will include training in
biostatistics, Work-in-Progress meetings, a cardiovascular seminar series, a hands-on didactic series in
cardiac anatomy, and career development seminars. Trainees will also participate in an annual retreat and
regular meetings attended by T32 trainees and mentors. Through these interchanges, clinically-oriented
trainees will gain understanding of fundamental cardiovascular biology, and basic science trainees will gain
understanding of important clinical problems. The program allows trainees to further tailor their training to
specific research interests by taking advantage of the stellar opportunities for formal coursework and the
myriad of scientific seminars and lectures at BCH, HMS, the Harvard School of Public Health, and MIT. We
also teach trainees the importance of teamwork, the clear communication of research findings, responsible
conduct of human and laboratory research, and mentoring skills. Milestones and metrics for trainee progress
and the training program itself are outlined and will be overseen by the RTEC. Considerable institutional
support includes supplementation of trainee stipends and travel funds, and support for the EAC and program
activities. Excellent training in rigorous experimental bench research and in translational and clinical
investigation within an interactive and vibrant program will prepare graduates to become leaders in pediatric
cardiology and cardiovascular research.

Public health relevance
NARRATIVE Pediatric cardiology, like all of medicine, is poised to benefit from burgeoning advancements in genetics, genomics, bioengineering, and developmental, cellular and molecular biology. It is also fertile ground for rigorous prospective clinical investigation related to bioengineering, transcatheter, and pharmacological interventions, as well as cell therapy and regeneration for selected cardiovascular diseases. This Training Program will recruit basic, translational, and clinical researchers to these tasks and train them to bridge the still substantial gap between the laboratory and the bedside in pediatric cardiology.